Leadership, Planning, and Evaluation

Leadership, Planning and Evaluation - Project Summary/Abstract
The Salk Cancer Center Senior Leadership consists of the Director, Reuben Shaw, the Deputy Director, Geoff
Wahl, the Associate Deputy Director, Jan Karlseder, Associate Director of Administration, Suzanne Simon, and
the Associate Director of Shared Resources, Tony Hunter.
Senior Leadership meets quarterly with the Cancer Center Program Leaders: Ronald Evans, Susan Kaech,
Clodagh O'Shea, and Inder Verma. This entire group of nine, along with Travis Berggren, the Salk's Executive
Director of Research Operations, is collectively referred to as the Salk Cancer Center Executive Committee
(SCCEC). The SCCEC meets quarterly to discuss all Cancer Center planning and goals, including
membership, faculty and staff hiring and recruitment, shared resources, space allocation, policies, and use of
Developmental Funds, which are critical for supporting the research efforts and infrastructure of the Salk
Cancer Center. These EC meetings also serve as occasions to share information and strategize about the
topics for the annual pilot grant RFA, one-day cancer symposia and larger international conferences on Cancer
held at Salk. Based on feedback from our last competing renewal, we have particularly enhanced the
responsibilities and authority of the Director.